Coordination of offsite enrollments and processing of clinical specimens for the

The Environmental Autoimmunity Group (EAG), NIEHS, enrolls subjects into some of its protocols offsite and has a need to send out enrollment kits to these subjects and to collect these back from them to process the blood and urine specimens that it receives and then send these to EAG. SAIC, Frederick, is an ideal contractor with extensive experience in this area.